Investigating apoptotic priming as a determinant of sensitivity to leukemia-directed therapies

PROJECT SUMMARY/ABSTRACT
Acute myeloid leukemia (AML) is a lethal blood cancer characterized by a clonal expansion of precursor blood-
forming cells. Intensive chemotherapy has been the mainstay of AML therapy for decades. Unfortunately, not all
patients are fit enough to receive it and mortality due to relapse despite intensive treatment is common. Recently,
the FDA approved a lower intensity regimen combining a hypomethylating agent, such as azacitidine (aza), with
the BCL2 inhibitor venetoclax (ven), based on phase 3 randomized data showing an overall survival benefit and
high response rates across AML prognostic subtypes. The success of aza/ven highlights the apoptotic pathway
as an exciting therapeutic target. Venetoclax induces apoptosis by antagonizing the anti-apoptotic function of
BCL2, one of many mitochondrial BH3-domain proteins that regulate the threshold at which an AML blast dies.
This apoptotic threshold, or priming, in viable leukemic blasts can be measured via a functional cell death assay,
called BH3 profiling. I have recently demonstrated that the cell of origin of leukemic transformation influences
apoptotic priming and resultant therapeutic sensitivity via alterations in p53 activity. I am interested in
understanding how AML cell state, whether established by AML genotype or apoptotic priming, can influence
drug sensitivity and clinical outcomes in the context of attenuated p53 function. I hypothesize that BH3 profiling
of AML patient samples can serve as a biomarker to predict treatment response to aza/ven. I also hypothesize
that complex cytogenetic changes – ensuing from mutant TP53-induced genomic instability – promote AML
progression and therapeutic resistance to aza/ven independent of mutant TP53. I believe that this work will
address important biological questions with therapeutic implications:
1. Can BH3 profiling assays predict treatment response to aza/ven in xenograft mouse models?
2. Which transcriptional and epigenetic pathways are engaged in AML cells with low apoptotic priming and
blunted responsiveness to aza/ven?
3. Is complex karyotype AML in the setting of TP53 loss of function a bystander phenomenon, or does it
enhance leukemogenicity and/or resistance to therapies such as aza/ven and chemotherapy?
Dr. Sheng Cai, an Assistant Attending at MSKCC, will conduct this study as part of his career development plan,
dedicating 85% of his time to research. Dr. Cai is mentored by Dr. Ross Levine, a world expert in hematologic
malignancies. He is also advised by Drs. Anthony Letai (who developed the BH3 profiling assay), Scott Lowe,
Michael Kharas, Richard Koche, and Andriy Derkach. Dr. Cai's training will include gaining knowledge in
biomarker validation and expertise in bioinformatics and genetic mouse models, with the long term goal of
developing a research program as an independent investigator in hematologic malignancies developing
functionalized biomarker assays for precision oncology.

Public health relevance
PROJECT NARRATIVE Acute myeloid leukemia (AML) is a fatal blood cancer with heterogeneous underlying genetics that can be treated, albeit with variable success, using either intensive chemotherapy, for those patients able to tolerate it, or less intensive regimens in combination with oral agents that trigger cell death in leukemic cells. We have adopted a functional test capable of measuring the intrinsic potential for a particular AML cell to undergo cell death, which we hypothesize will predict treatment response to cell death-inducing agents and thus identify patients most likely to benefit from a specific treatment. The proposed research will also seek to distinguish mutations present in poor-risk TP53-mutant AML as bystander mutations or drivers of AML disease progression which mediate resistance to standard therapies.